Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology

Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology
Project Summary/Abstract
The goal of the Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology
(DF/HCC K12) is to prepare the next generation of clinical investigators in oncology to work at the interface of
laboratory science, clinical medicine, and population science. The DF/HCC K12 was first funded in 2002 and
has supported 23 Scholars, with an additional 12 Scholars who received 2 years of support through a Federal
Share mechanism. The Program emphasizes research training in molecular oncology and its application to
clinical medicine. The 18 K12-funded Scholars who completed participation have been exceptionally
successful, with an output of 564 publications, 77 grants, and all Scholars progressing to independent faculty
positions. We propose the renewal of this K12 to continue training clinicians from diverse disciplines, including
adult hematology/oncology, pediatric hematology/oncology, and radiation oncology to design and conduct
hypothesis-driven clinical oncology trials. To enhance our highly successful K12 program, we propose the
following Specific Aims:
Aim 1: We will recruit and select a diverse group of K12 Scholars. We will issue an annual Request for
Applications (RFA) using a variety of mechanisms to reach the widest possible audience of candidates. We
will aggressively promote the participation of women and other groups traditionally under-represented in
medicine. Eligible candidates come from a large and highly qualified pool, including senior fellows and junior
faculty within Dana Farber/Harvard Cancer Consortium (DF/HCC) institutions who have completed
subspecialty clinical training. Non-clinician postdoctoral researchers are not eligible for participation. An
Internal Advisory Committee (IAC), comprised of 20 DF/HCC faculty members with leadership roles and
established track records in original research and mentoring, will assist Program Leadership with Scholar
selection. We request a continuation of support for five Scholars per year with five year appointments.
Aim 2: We will provide a program of rigorous didactic training, career development, and mentored
clinical oncology research. Each Scholar will be guided by two Faculty Mentors, one for laboratory (or data
science) training, and one for clinical investigation. A group of 34 highly qualified and motivated Faculty
Mentors have been identified, but Scholars may elect to include additional mentors from the pool of >1,100
investigators within the seven DF/HCC institutions, as well as faculty from the Koch Institute at MIT and the
Broad Institute of Harvard and MIT. An individualized career development plan will be devised that includes
components of required and optional didactic training, hands-on laboratory research, and development of a
clinical trial. Scholars will share results and participate in networking activities at an annual retreat.
Aim 3: We will monitor the performance and refine the K12 Program to optimize recruitment and
training of new investigators in clinical oncology research. The IAC will review annual progress reports
from Scholars and Mentors and make recommendations for changes in mentoring and/or research focus, as
needed. An External Advisory Committee (EAC), comprised of five PIs from other successful K12 Programs,
will evaluate Program performance, participate in the annual retreat, and provide recommendations for
Program enhancements to the K12 Leadership. The Program will track Scholar productivity, including
presentations, publications, grants, and clinical trial activity on an annual basis.

Public health relevance
Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology Project Narrative New insights from genome sequencing and technical advances in genome editing, chemical biology, and cellular engineering are providing unprecedented opportunities for advances in cancer treatment. The emerging complexity of cancer biology and increasing sophistication of experimental therapeutics demand a level of understanding and training in research methodology beyond the scope of conventional fellowship programs. To address these challenges, the goal of the Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology (DF/HCC K12) is to recruit and select a highly qualified and diverse group of Scholars to complete a rigorous five year program of didactic instruction and mentored research that will prepare them for independent careers in clinical oncology research.